Genomic Sciences Core

PROJECT SUMMARY – GENOMIC SCIENCES CORE (GSC)
The goal of the Genomic Sciences Core (GSC) is to provide geroscience researchers across the country with
access to state-of-the-art genomic and epigenomic analyses targeted to biology of aging research questions and
that are not typically provided by institutional cores. Specifically, the GSC will offer services related to the
analysis of mitochondrial genomes, DNA modifications (methylation/hydroxymethylation), and epigenomic
clocks. In coordination with the GeroInformatics Resource, these services will take investigator-submitted
samples from data generation to analysis and interpretation. In the previous cycle, our epigenomic, mitochondrial
genomic, and transcriptomic services were widely used in a variety of geroscience studies and investigators from
across the US. New services will integrate nanopore whole genome epigenomic analyses, digital PCR analyses
of mitochondrial copy number, and epigenomic clock analyses. The rationale for focusing services in these areas
is that; 1) Accumulation of mitochondrial DNA mutations/deletions and copy number changes are a central
mechanistic hypothesis of mitochondrial dysfunction with aging, 2) Epigenetic mechanisms are a conserved, and
potentially causative, factor in aging (increasing evidence demonstrates that not only does the epigenome
change with aging, but anti-aging interventions can prevent age-related changes to the epigenome), and 3)
Epigenomic clocks may provide a common index of biological aging and efficacy of ant-aging interventions.
Central to the design of the GSC services are bioinformatic workflows to take investigators from sample
submission to fully analyzed data. The GSC will have three aims: 1) Perform quantitatively precise DNA
modification analyses, ranging from genome-wide to gene-specific using advanced epigenetic technologies, 2)
Measure mitochondrial genome heteroplasmy and copy number for comprehensive variant analysis and
absolute quantitation, and 3) Epigenomic clock analyses for murine studies. GSC services are designed such
that aging research investigators can take advantage of specific analyses or whole workflows that meet their
experimental needs, and all services can be performed on stored nucleic acid samples. The Genome Sciences
Core has developed a set of tools highly relevant to aging research that are not widely available to investigators,
either in their own laboratories or through institutional core facilities, both in terms of instrumentation and
expertise, meeting a need for a resource provider in the field. Furthermore, the interaction with the
GeroInformatics Resource provides a workflow where not only can geroscience investigators from across the
country have data generated by the GSC but it is analyzed into an investigator-usable format.